UNE Center for Cell Signaling Research

Cellular systems such as the nervous, immune, vascular systems and bone do not work in isolation, but are functionally
integrated and communicate extensively both in health and disease states. Defects or dysfunction in cell signaling are
fundamental drivers of human disease, and our ability to meet contemporary clinical challenges, including
neurodegenerative and metabolic disease, chronic pain and optimizing healthy aging, requires a broader understanding of
mechanisms of intercellular and intracellular communication. The proposed UNE Center for Cell Signaling Research
(CCSR) will build a critical mass of talented investigators with a broad research emphasis on cellular metabolism,
inflammation and aging. The initial Research Project Leaders (RPLs), selected through a competitive process, bring
diverse and complementary expertise from across UNE colleges and departments. Their research projects address discrete
clinical challenges by investigating fundamental cell biological mechanisms that may have broad ramifications for human
disease. New faculty recruitment and support of a pilot project program will ensure a continued pipeline of RPLs and
further grow the Center. Investigators will be provided with a structured mentorship program to support both their
professional and research program development in their progression to independent funding and beyond. The proposed
Center will also expand the research infrastructure at UNE to support the innovative research programs of investigators
in cell signaling. The proposed In Vitro Analytical Core will support the research of the RPLs with outstanding
instrumentation and innovative services that are not broadly available elsewhere in the region, including primary cell and
cell line culturing, transfection and analysis through functional imaging as well as transcriptional and protein-based
analysis. The core will be housed in newly renovated research space that will be contiguous with an existing UNE
Histology and Imaging Core, providing a unique suite of resources to support research at UNE. Institutional commitments
include additional protected research time for RPLs and institutional matching funds for the pilot project program. In
addition, the university has committed to hiring 3 additional investigators whose research programs will complement
those of the existing faculty. The Center will also benefit from strong continued institutional investment into research
infrastructure, as well as well-established collaborations with neighboring IDeA state programs in Maine and New
Hampshire. Research infrastructure will be enhanced by laboratory renovations, purchasing new instrumentation, and key
support for personnel. Additional institutional support has been committed for each of these. With sound financial and
administrative management and regular assessments of performance with specified bench marks, the CCSR will be well-
positioned to make a significant impact in optimizing healthy, pain-free aging and in finding new treatments for
neurodegenerative and metabolic diseases.

Public health relevance
Dysfunction in cell signaling is a fundamental driver of human disease, and our ability to optimize healthy, pain-free aging and find new treatments for neurodegenerative and metabolic diseases requires a broad understanding of the way cells communicate. The Center for Cell Signaling Research will build critical research infrastructure and support the research programs of junior investigators to meet these contemporary clinical challenges.